Augmenting the CMDKP with advanced features for understanding biological mechanisms

Title: Augmenting the CMDKP with advanced features for understanding biological mechanisms
Project Summary
The Common Metabolic Diseases Knowledge Portal (CMDKP) aggregates genetic, genomic,
and phenotypic data to accelerate discovery of therapies for type 2 diabetes and related
common metabolic disorders. Under the parent UM1 grant we have (a) identified and
aggregated datasets for inclusion in the portal; (b) implemented bioinformatic pipelines for
processing these data through methods for predicting the effects of GWAS associations; and (c)
built interfaces to access an integrated resource of these datasets and method results. This
work has produced a widely used knowledge portal and made important advances in increasing
genetic and genomic data accessibility. To increase the impact of the portal on the ultimate
AMP-CMD goal of informing on all major questions regarding genetically driven target
identification and validation, in this supplement we will make higher-level queries about common
metabolic disease mechanisms easier to address through the CMDKP. We will address this
goal in three ways. First, we will extend and apply statistical methods to hierarchically extract
and organize information from genetic and genomic datasets within the CMDKP. These
methods will allow us both to present higher-level relationships among biomedical entities that
can be more easily interpreted and queried by users, and it will also allow users to more easily
organize and locate functionality and datasets within CMDKP. Second, we will improve the user
interface of the CMDKP to make it easier for users to conduct integrative queries of its
functionality. We will achieve this by taking advantage of new AI technologies for large language
models to redesign the CMDKP user interface, and we will also make the results of the CMDKP
available as a knowledge graph and open API catalogue that large-language models can invoke
via function calling. Finally, we will improve user access to the new results and functionality
within the CMDKP through new outreach and training approaches. These new approaches will
target CMDKP data contributors, method developers, and users, taking advantage of new AI
technologies that allow us to tailor training to each user’s background. Collectively, this work will
significantly extend the CMDKP with the next generation of tools to use genetic and genomic
data to understand common metabolic disease mechanisms and ultimately develop new
treatments.

Public health relevance
Project Narrative In this supplement we will build upon the successful Common Metabolic Diseases Knowledge Portal to augment it with advanced features for understanding and querying common metabolic disease mechanisms. We will achieve this by implementing new statistical methods, improving the organization of its user interface, and investing in AI-forward user training and outreach. Our goal will be to realize the full potential of data generated by the AMP-CMD consortium to advance genetically driven discovery and validation of treatments for common metabolic diseases.